Intracranial Hypotension Secondary to Spinal CSF Leaks

Project Summary / Abstract Intracranial Hypotension Symposium This conference titled “Intracranial Hypotension Secondary to Spinal CSF Leaks” shall be the first full-day multidisciplinary symposium on the topic. This single full-day conference will be held on October 14, 2017 in Los Angeles, CA. Our objectives are as follows: (a) to bring together top clinicians and researchers to advance diagnostics and treatments of this under-diagnosed, disabling but treatable secondary headache disorder; (b) to elevate awareness and interest in the medical community to reduce the burden of suffering; (c) to establish priorities for and to inspire future research; (d) to support learning of those suffering with intracranial hypotension. The target audiences are (a) neurologists, other physicians and health care providers; (b) potential and current investigators; and (c) individuals with intracranial hypotension and their families and is inclusive of under-represented communities. The speakers will include representation from a range of subspecialties, including neurology, neurosurgery, neuroradiology, pain management / anesthesiology, family medicine, clinical genetics, as well as from patients. There will be shared sessions, a professional track and a patient/caregiver track. The keynote session will be presented by Bahram Mokri, MD, who is generally regarded as the physician expert who first elevated awareness of spontaneous intracranial hypotension. Professional track sessions will cover current aspects of clinical findings and diagnosis, etiology, diagnostic imaging, percutaneous interventions and surgical approaches. A track for patients and caregivers will provide an overview and update on the current diagnosis and treatment of intracranial hypotension as well as information to empower patients in improving outcomes and quality of life. Challenging cases will be submitted in advance for review and discussion by a team of experts. A panel of clinicians and researchers will have a round-table discussion of priorities for research and developments.

Public health relevance
Project Narrative Intracranial Hypotension Symposium Intracranial Hypotension secondary to spinal cerebrospinal fluid (CSF) leaks is an under-diagnosed cause of disabling headache that is treatable. This conference will bring together top clinicians, researchers and individuals who suffer with this disorder to elevate awareness and interest in the medical community, stimulate further research and to reduce the burden of suffering.